POSTDOCTORAL PROGRAM IN COMPARATIVE MEDICINE RESEARCH

This is a new research training program to prepare laboratory animal veterinarians as independent investigators. Trainees will work with a cohesive training faculty that conducts independent and collaborative research. The training program will emphasize basic research applying molecular, genetic, biochemical, and immunological techniques to approach biological problems. A broad-based curriculum supplemented with seminars and literature reports supplements the research training. Candidates for research training will be graduate veterinarians who have successfully completed postdoctoral training in basic laboratory animal medicine, demonstrated research competence, and plan a research-oriented career. Funds are requested for six positions per year (2 first-year, 2 second-year, and 2 third-year trainees). The trainers have outstanding laboratory facilities for trainees. In addition, important institutional resources include the Animal Resource Facility, Center for Biostatistics and Epidemiology, Flow Cytometry Laboratory, Macromolecular Core Facility, George T. Harrell Library, and multiple computer facilities.